Gastrointestinal Experimental Model Systems Core

PROJECT SUMMARY: Gastrointestinal Experimental Model Systems Core (Biomedical Research
Core)
The Gastrointestinal Experimental Model Systems (GEMS) Core meets the experimental and scientific needs of
the members of the Texas Medical Center (TMC) Digestive Disease Center (DDC), and supports the DDC’s
overall theme and mission.
The GEMS Core is subdivided into two subcore: 1) organoid, and 2) gnotobiotic sub-cores. The Core’s
centralized services support exciting scientific developments, are based on the unique expertise of the Core
leadership, and facilitate the use of cutting-edge model systems by DDC members. The Core maintains and
supplies DDC members with experiment-ready organoid cultures and gnotobiotic rodents. The Core’s
organizational structure reduces cost burden for members, increases efficiency, saves time, and provides quality
control for each project. The overall goal of the GEMS Core is to provide DDC members with state-of-the-art
experimental model systems that are difficult to initiate and maintain in independent labs. There is no similar
facility in the TMC or the region.
The Specific Aims of the GEMS Core are to: 1) generate, maintain, and provide experiment-ready
gastrointestinal tract organoid cultures and specialized growth reagents for membership use; 2) increase the
complexity of organoid models to study infection and injury; 3) produce, house, manipulate, and colonize
gnotobiotic animals per the needs of DDC members; and, 4) establish housing and embryo transfer conditions
to improve the overall efficiency of the gnotobiotic model.
The GEMS Core has extensive interactions with the Study Design and Clinical Research Core, the Tissue
Analysis and Molecular Imaging Core, and the Functional Genomics and Microbiome Core. The GEMS Core will
continue to respond to the needs of DDC members and develop new services to meet them. The Core has been
heavily used by the 103 DDC members this cycle: organoid subcore by at least 31, gnotobiotics by 29 with nearly
3000 service requests resulting in over 80 publications.

Public health relevance
PROJECT NARRATIVE: Gastrointestinal Experimental Model Systems Core (GEMS) Per instructions in RFA-DK-21-026, we have not included a project narrative in this application. As specified, we have included the narrative in the overall component.